Phase III Multicenter Study of Magnetic Mini-Mover for Pectus Excavatum G090006 1

ABSTRACT Pectus excavatum is the most common congenital chest deformity. This defect is characterized by malformed costal cartilages causing a depressed sternum. Surgical correction requires major surgery, hospitalization for pain control, and costs of $60,000 to $80,000. The Magnetic Mini- Mover Procedure (3MP) is an outpatient procedure that uses a magnetically coupled implant to pull the sternum forward and gradually remodel the deformed costal cartilage. In an ongoing FDA-sponsored phase I-II study (R01 FD003341), we are studying the safety and probable efficacy of the 3MP in 10 patients ages 8-14 years with Pectus Severity Index > 3.50 (normal = 2.56). Interim analysis demonstrates that the 3MP is a safe, outpatient, minimally-invasive, and cost-effective treatment for pectus excavatum, that brace-wear compliance was 10-21 hours/day (mean 16.8 h/day), and that the pectus deformity improved more rapidly in pre- pubertal patients. In addition, this initial phase I-II trial has led to minor improvements in the titanium-encased magnetic implant (Magnimplant) and major improvements in the external magnet brace (Magnatract). The second generation Magnatract allows the patient to adjust the force applied, measures the force by an indwelling pressure sensor, logs force and temperature every 10 minutes, and downloads the data securely over the Internet. Consultation with the FDA suggested that further data on safety and probable efficacy and demonstration that the procedure can be safely used at other centers would allow application for a Humanitarian Device Exemption (HDE). We will now extend the findings of the initial trial in a phase III study that incorporates the improvements from the first trial in the second generation Magnetic Mini- Mover Procedure (G090006; 02 Jan 2009). We propose enrolling 15 additional patients ages 8- 12 with Pectus Severity Index > 3.50 at three centers.

Public health relevance
RELEVANCE Substantial improvement can be achieved in what is currently the standard of care (Nuss and modified Ravitch procedures) in the treatment of pectus excavatum. We have developed a procedure that is safer, easier, less morbid and painful, and less expensive. We believe this new approach could significantly improve our patients' lives, improve respiratory and cardiovascular capacity, and improve their self-image. We aim to replace a major surgical reconstruction with a minimally invasive, gradual reformation of the chest wall, at a savings of roughly $108 million annually in benefits.